NPGH LEADERs - ODP - Thiyagarajan

Over the past ten years, our consortium Universities in Hawaii, Michigan, Minnesota, and Washington have
provided research training to 221 Fogarty Global Health Fellows and Scholars, who to date have generated
866 publications. With this competitive renewal, we propose to expand training activities aimed at increasing
the likelihood of trainees becoming independent global health scientists and leaders. We have modified our
consortium name to reflect this new emphasis: Northern Pacific Global Health Leadership, Education, And
Development for Early-career Researchers (NPGH LEADERs). We propose to continue partnerships based in
nine countries: Kenya, Uganda, Ghana, Cameroon, Liberia, Peru, Thailand, Nepal, and India. To achieve our
objective of developing the next generation of independent global health scientists and leaders, we will offer
12-month research and leadership training with the following specific aims: Aim 1: To ensure excellence in
scientific inquiry, trainees will complete a comprehensive curriculum in global health research, including how to
frame novel, relevant, and feasible scientific questions, prepare detailed scientific protocols, and plan for the
implementation of a mentored research project in a low- or middle-income country. Aim 2: To address the
challenges of research implementation in a low-resource setting, trainees will follow an explicit, expedited,
supported, and mentored progression from research planning to pragmatic implementation and process
management. Aim 3: To prepare trainees for careers as independent scientists and to excel in both leadership
and management, we will support trainees in development of individualized “road maps” to define the research,
management and leadership skills necessary for their transition into independent investigators. We will also
expand alumni support for alumni to further strengthen the scientific and leadership skills necessary for
transitioning to the next generation of independent global health scientists. The four U.S. universities, as well
as Indiana University - an associated partner since 2016 - have committed cost-sharing funds totaling
$565,000 to increase recruitment and retention of underrepresented minorities and a second year of fellowship
for the most productive fellows. We anticipate supporting at least 10 trainees each year, for a total of 50
trainees over the five year grant period; 60% of trainees will be at the U.S. postdoctoral level and 40% will
implement HIV-related research projects.

Public health relevance
This proposal is to establish the Northern Pacific Global Health Leadership, Education, And Development for Early-career Researchers (NPGH LEADERs) Consortium – a research training program directed by the University of Washington in partnership with the Universities of Hawaii, Michigan and Minnesota with international partnerships in Cameroon, Ghana, India, Kenya, Liberia, Nepal, Peru, Thailand, and Uganda. The goal of this Consortium is to provide outstanding mentored research training to U.S. and LMIC post-doctoral and U.S. pre-doctoral trainees at international partner institutions in order to create the next generation of independent global health scientists and leaders.